Training Program in Nervous System Tumors

Project Summary
We propose continuation of a multidisciplinary research training program in neuro-oncology based at the
Massachusetts General Hospital Cancer (MGH) Center but integrating programs from across the 7 institutions
comprising the Dana-Farber/Harvard Cancer Center, Harvard School of Public Health, and the Massachusetts
Institute of Technology. The primary objective of this two-year program is to train physician-scientists capable
of providing a critical bridge between the biological sciences and experimental therapeutics. In order to
achieve this objective, the training program emphasizes a didactic curriculum in clinical research
methodology, mentor-supervised clinical and basic science research experiences, and ongoing Scholar
monitoring and feedback. All Scholars are assigned a clinical trial project during the course of the training
program. All 40 clinical and laboratory mentors participating in this training program have extensive
experience in neuro-oncology research and training, active research funding, and provide an excellent
resource for Scholars interested in translational research. All Scholars have access to dedicated biostatistical
and computing support on all projects. An Internal Advisory Committee, as well as an External Advisory
Committee, oversee the training program. There is no significant overlap between our unique grant focused
on nervous system tumors and other training grants at Harvard focused on medical oncology. Candidates
include physicians completing clinical training in adult and pediatric neuro-oncology, adult and pediatric
neurosurgical oncology, adult and pediatric medical oncology and radiation oncology. A qualified pool of
applicants from these disciplines can be expected to grow from existing and developing sources. Each
Scholar has a dedicated two-year block for research and training with minimal clinical responsibilities. Four
postdoctoral positions are requested per year for five years with each Scholar making a two-year commitment
to investigation. Applicants will be solicited through advertisements, and by active recruitment by the program
and individual faculty. The training program remains committed to recruitment of a diverse Scholar pool. We
believe that the proposed training program capitalizes on a group of outstanding mentors and superb training
facilities and will have the capability to produce productive patient-oriented researchers in neuro-oncology.
Since the original award 20 years ago, the quality of the program has steadily improved based upon such
metrics as diversity in Scholar clinical specialties, Scholar publications, Scholar academic positions, Scholar
leadership of national clinical trials, and Scholar grant awards.

Public health relevance
Project Narrative This grant is designed to train neuro-oncologists – including adult and pediatric specialists in neurology, neurosurgery, radiation oncology, oncology, and radiology -- in the methods of research. The training program will expose the physician to coursework and hands-on experience in the laboratory. It is anticipated that after their training, graduates will continue to advance the field by developing clinical trials to test new treatments for patients with primary and metastatic tumors of the nervous system.